Determining function and mechanism of lncRNA Chast in Trypanosoma cruzi infection and dissemination

Chagas disease (CD), caused by parasite Trypanosoma cruzi (Tc), is endemic in Latin America. CD
has become a global health problem because of the human migration from endemic to nonendemic
areas. The delayed and sup-par immune activation of macrophages (Mφ) allows parasite dissemination
and persistence that ultimately results in cardiomyopathy and heart failure in infected patients.
Understanding of how Tc deregulates Mφ function will aid in the development of novel therapeutics with
broader relevance to control of intracellular pathogens.
Long non-coding RNAs (lncRNAs) have emerged as regulators of multiple biological functions via
their effects on epigenetic, transcriptional, and translational programs. Yet, the role of lncRNAs in the
regulation of host response to pathogens is not well studied.
Our preliminary studies using global and targeted molecular approaches and publicly available
databases identified that LncRNA Chast is downregulated in Tc infected Mφ. Genomic locus of lncRNA
Chast forms a chromatin loop with a nearby protein-coding gene Plekhm1, and RNA binding protein
EZH2 has a binding motif near the promoter of the Plekhm1 sequence. Experiments using primary and
cultured murine Mφ showed that Plekhm1 gene expression was downregulated, EZH2 was enriched at
the Plekhm1 locus, and Chast-EZH2 binding was decreased following Tc infection. Further, RNAi
mediated Chast deficiency enhanced parasite survival in Mφ.
Building on these preliminary results, it is hypothesized that T. cruzi deregulates lncRNA Chast
to repress EZH2-mediated Plekhm1 gene expression which ensures parasite survival in and
escape from Mφ. Cutting-edge molecular biology and immunology tools along with in vitro and in vivo
models of Tc infection will be utilized to test this hypothesis in two aims. Studies in Aim 1 will examine
whether Tc deregulates Chast-Plekhm1 to hijack host defense mechanisms for its intracellular survival
and dissemination. Studies in Aim 2 will uncover the molecular mechanisms by which Chast-EZH2
regulate the Plekhm1 gene expression and influence Mφ functional activation vs. parasite
dissemination. Rigor of the findings will be tested by including cardiomyocytes and heart tissues under
similar experimental conditions.
The proposed work is highly innovative and will reveal fundamental molecular mechanisms driving
T. cruzi to evade immune responses and establish persistent infection in the host. The experiments
outlined in the proposal will establish a new role of lncRNA Chast in parasite survival and will lead to
development of potential novel therapeutics against T. cruzi infection.

Public health relevance
PROJECT NARRATIVE Trypanosoma cruzi, a parasitic protozoan, is the causative agent of Chagas cardiomyopathy and heart failure. Studies in this proposal will examine the underlying mechanisms by which lncRNA Chast and PLEKHM1 protein influence host macrophage longevity and activation, and how the parasite exploits this system to ensure its survival in the infected host. These studies may provide the foundation for the development of novel host-targeted therapeutics against Chagas disease.